Network analysis of bodywide coordination supporting suprapostural dexterity

Prevailing understandings of movement disorders characterize "broken...... movements in a piecewise
fashion, for instance, focusing on motor control, muscle tone, posture, or cognition independently of each
other. These fractured approaches to movement coordination are blind to the body's functional integrity.
Consequently, rehabilitative interventions target the limb or body parts most affected by the disorder
seeking to support the whole body by mending the broken part. However, dexterity is global, functional
coordination spanning the whole body. In other words, task completion draws on fundamental interactivity
allowing the body to coordinate various anatomical parts. This coordination may be more vital to healthy
movement than individual anatomical parts. Understanding this interactivity is thus paramount to
developing novel rehabilitative interventions to prevent falls and improve the quality of life in pathological
populations. Studying bodywide coordination for suprapostural dexterity requires innovation in
experimental setup and analytical techniques. This project integrates a customizable life-size Trail Making
Test with posturography, whole-body movement tracking, and eye tracking, along with state-of-the-art
cascade modeling and network analysis methods to assess functional coordination across the whole
body. We will leverage causal network analyses of multiplicative interactions instrumental in previous
studies of whole-body exploratory motor behavior but not yet utilized in studying suprapostural dexterity.
Aim 1 will investigate how multiplicative interactions among movement-system components support
suprapostural dexterity. We hypothesize that maintaining an upright stance would produce a functional
network of multiplicative interactions among movement-system components. We also hypothesize that
participating in the Trail Making Test would produce a succession of distinct, modular networks of
multiplicative interactions among movement-system components. Aims 2 will investigate how
multiplicative interactions among movement-system components support suprapostural dexterity in the
face of postural instability. We hypothesize that destabilizing contact with the ground surface when
maintaining an upright stance will produce modular networks of multiplicative interactions with increased
connectivity among these modules compared to stable standing.

Public health relevance
The proposed project and the modeling framework it entails offer a new way to understand suprapostural dexterity and its breakdown in various movement disorders in light of recent theoretical developments in cascade modeling and network physiology.